ICSC Core - Coordination

PROJECT SUMMARY – CORE: COORDINATION
The Coordination Section will effectively coordinate interactions and collaboration across the entire MMRRC
Consortium, including Center PIs, management and technical staff, as well as coordinate activities with the
ORIP/DPCPSI/OD/NIH Program Official. The ICSC will facilitate the coordination and collaboration of all internal
activities within the ICSC structure of curation, customer service, information services, and
marketing/outreach. In addition, the ICSC will facilitate and coordinate participation in MMRRC Consortium
evaluation activities, including progress reports, site visits and providing communication materials to
the ORIP/DPCPSI/OD/NIH Program Official as needed.